Regulation and mechanism of RND-mediated antibiotic efflux in Pseudomonas

ABSTRACT
Bacterial resistance to antibiotics is an escalating crisis in healthcare that threatens to fundamentally alter
modern medicine. Among several prevalent mechanisms of resistance, intrinsic multidrug efflux pumps of the
Resistance-Nodulation-cell Division RND superfamily are broadly distributed among pathogenic bacteria
(particularly Gram-negatives) and contribute extensively to clinical resistance. The important opportunistic
pathogen Pseudomonas aeruginosa encodes multiple RND efflux systems, at least four of which contribute to
its intrinsic multi-drug resistance. P. aeruginosa can cause both acute and chronic infections in susceptible
individuals that are thus notoriously difficult to treat once established. The P. aeruginosa multi-drug RND pumps
possess overlapping but distinct antibiotic substrate specificities, e.g., MexAB-OprM is selective for b-lactams
and MexXY-OprM for aminoglycosides, while both can efflux macrolides and other drugs. Expression of the P.
aeruginosa RND efflux system MexXY-OprM is also distinct in that it is upregulated in response to
aminoglycoside antibiotics. However, the molecular bases of gene regulation via aminoglycoside treatment and
aminoglycoside substrate selection for efflux are currently not known. The Specific Aims of this collaborative and
interdisciplinary proposal will generate a comprehensive new understanding of MexXY-OprM gene regulation,
structure and activity. This program will involve five researchers with highly complementary expertise in ribosome
stalling/ structural biology (Dunham and Keiler); computational/ structural biology and aminoglycoside activity/
resistance (Conn and Dey); and, bacterial genetics and P. aeruginosa biology (Grabowicz and Goldberg). The
two complementary, but independent, Specific Aims will: Aim 1–Uncover novel aspects of P. aeruginosa
physiology to define the cellular and molecular processes that lead to MexXY expression upon aminoglycoside
treatment; Aim 2–Determine the molecular basis of aminoglycoside uptake, selection, and efflux through the
MexXY-OprM transporter protein, MexY. Collectively, these studies will reveal important new aspects of P.
aeruginosa biology and identify multiple potential new strategies for new anti-pseudomonal development. Our
studies will also have broader implications for understanding the biology and potential therapeutic targeting of
RND efflux pumps in other important human pathogenic bacteria.

Public health relevance
NARRATIVE The ability of bacteria to actively export (efflux) antibiotics is a prominent mechanism of drug resistance, common among many serious bacterial pathogens and a major contributor to the escalating global antibiotic resistance health crisis. This proposal aims to define the molecular mechanisms that regulate expression and activity of one such efflux pump in an important bacterial pathogen. These studies will broadly enhance our understanding of bacterial responses to antibiotics and bacterial efflux drug systems, and will support the future goal of developing novel strategies to counter the antibiotic resistance they confer.